Investigating the role of Crest, an epigenetic mechanism coordinator, in the adult and aging/AD brain

Project Summary/Abstract
In 2021, an estimated 6.2 million age 65 and older individuals in the United States are living with Alzheimer’s
disease (AD). In AD, aging is the leading risk factor and with increases in life expectancy, there is an urgency to
better understand the overlapping or distinguishing molecular processes associated with cognitive decline in
aging and AD memory impairments. As previously demonstrated by our lab and others, hippocampus-dependent
learning becomes less resilient to aging and even more impaired in AD. AD has an unmet need for treatments
that offset disease onset, progression or show recovery of cognitive function. One possible target for treatment
development is the epigenetic machinery. The Wood lab has made significant contributions to our current
understanding of the epigenome in learning and memory, such as histone acetylation/deacetylation and
nucleosome remodeling in regulating gene expression required for memory consolidation. Although we know
that the regulation of the epigenome is important for long-term memory formation, it is unknown how different
epigenetic mechanisms are coordinated for facilitating gene expression necessary for memory consolidation.
The discovery of Calcium-RESponsive Transactivator (CREST; aka SS18-like protein 1) provided a prime
candidate for a transcriptional regulator with the capacity to interact with multiple epigenetic mechanisms.
CREST is able to coordinate histone modification and nucleosome remodeling mechanisms using two distinct
domains: the C-terminus interacts with the potent histone acetyltransferase, CBP (Creb-binding protein),
whereas the N-terminus interacts with BRG1, a key enzyme of a nucleosome remodeling complex. As a potential
key coordinator of major epigenetic mechanisms, CREST is also a major weak point for molecular mechanisms
going awry, leading to cognitive impairment. For example, mutations in the human Crest gene have been
implicated in ALS, a neurodegenerative disease, and my preliminary data shows an age-dependent decrease in
CREST and that decreasing CREST expression impairs synaptic plasticity and memory. The proposed research
strategy will test the hypothesis that CREST is critical for epigenetic gene regulation during memory formation
in the adult brain and that its function becomes impaired with age and AD onset. The specific aims of this proposal
will examine the following in the adult, aging and AD brain: Aim 1, Determine the role of CREST in hippocampal
synaptic plasticity in the adult and aging brain; Aim 2, Determine the role of CREST in hippocampus-dependent
memory in the adult and aging brain; Aim 3, Determine CREST-dependent gene expression and chromatin
accessibility during memory consolidation in the adult and aging/AD brain. The outcome of this research will
provide new innovations and insight into how we understand the regulation of memory consolidation in the adult,
aging, and AD brain and outline key functional avenues to pursue for more effective AD treatment development.

Public health relevance
Project Narrative Memory decline with normal aging and Alzheimer’s disease-related dementia (ADRD) are both a source of negative factors on cognitive function and ultimately impact well-being and quality of life for the growing 65+ year old community. While current studies implicate one epigenetic mechanism or another as an underlying cause of memory impairment to either characterize or distinguish normal aging decline from ADRD, there is little known about how epigenetic machinery is coordinated for memory formation and whether this process loses efficiency in the aging brain. This research proposal will investigate the role of CREST, a transcriptional regulator that bridges multiple epigenetic mechanisms, in regulating long-term memory formation, synaptic plasticity, and expression of specific genes during memory consolidation in the adult and aging/AD brain.